Training in Child Health Services Research and Implementation Science

This renewal application builds on the expertise of an experienced and dedicated faculty with a 23-year history
of leading successful AHRQ-funded, post-doctoral NRSA training programs focused specifically on pediatric
health services research. In an increasingly dynamic US health care system, meeting the needs of children will
require health services researchers to be trained in novel and wide-ranging methods to study and improve the
effectiveness, efficiency, and equity of health care. Through expanding faculty and partnerships, our program
stands ready to meet the needs of our trainees to tackle health services research that builds on advances in
science, technology, and data analytics, including genomics; data mining and machine learning; novel
diagnostics and therapeutics; and information technology. In this renewal, we will continue the core
programmatic collaborations among Boston Children's Hospital, the MassGeneral Hospital for Children, and
the Department of Population Medicine at Harvard Medical School as well as the successful engagement of
our newest partner—the Institute for Healthcare Improvement—which has brought its recognized expertise in
care improvement and implementation science to our trainees through curricular enhancements and research
opportunities. As both the development of research and its implementation are increasingly informed by
patients and the patient experience, our program will continue to engage patients and parents to provide
substantive feedback on trainees' current and future research, as an integral aspect of our program's culture.
For this renewal, we will also engage with new partners to address the expanding role of information
technology in healthcare. Our program will focus on four pillars of training: 1) cutting edge observational
methods to learn from health and health system data; 2) application of implementation science and related
methods to improve the design, delivery, and evaluation of care for children across a variety of financing and
delivery systems; 3) incorporating the perspective of patients and families into the process for designing and
conducting research; and 4) framing research in children as a part of health over the life course, especially the
pervasive, enduring impact of disparities in care and services. The program will support 6 stipends per year (3
first-year and 3 second-year continuing postdoctoral fellows) to create a critical mass of trainees across
subspecialties, areas of research, and methodological domains. In addition to conducting closely mentored
research, each trainee will complete the requirements of an MPH from the Harvard T.H. Chan School of Public
Health for core skills of biostatistics and epidemiology, and participate in advanced health services research
methods training. Our well-developed program infrastructure and system for close monitoring of trainees'
progress will ensure the continuation of our record of graduating individuals who will lead relevant, applied
health services research that translates into both improved care and health outcomes for all children.

Public health relevance
The proposed renewal will continue our successful program to train child health researchers to conduct meaningful research leading to improvements in health care delivery for children. The program will include training in the established building blocks of health services research (epidemiology, statistics, and study design) as well as methods of improvement and implementation science. Trainees will be equipped to engage with the evolving US healthcare system, focusing on research that reduces health and health care disparities, is informed by the patient perspective, and is ready for integration into clinical delivery systems. Our graduates will help to transform the current health care system to be more efficient, effective, and patient and family-centered for all children.